Midwest Roybal Center for Health Promotion and Translation

Our proposed UIC Midwest Roybal Center for Health Promotion and Translation seeks to accelerate the
translation of behavioral research interventions into practical outcomes to improve the functioning (cognitive
and physical) and quality of life of older adults at risk of Alzheimer’s Disease and Alzheimer’s Disease Related
Dementias (AD/ADRD). Our work recognizes that interventions that target individuals take place in families,
neighborhoods, and communities that are impacted by external factors that influence initiation and
maintenance of behavior change. Our work is guided by the PRISM Framework to identify behavioral
interventions that have the greatest potential for broad public health impact. Our Center will support the design
and testing of principle-driven and mechanism-focused, potent and sustainable health promotion interventions
that have a strong promise of progressing through the NIH Stage Model. Our renewal Center retains its
current focus on designing interventions for older racial/ethnic minority adults and expands our focus to target
older adults at risk of AD/ADRD with a focus on behavioral interventions that address cognitive health. This
renewal application targets four thematic areas of focus: Develop and test principle driven interventions to
increase physical activity (PA) among older adults at risk of ADRD, Design interventions to maintain and/or
enhance cognitive function and mobility; harness technology to improve intervention scalability and fidelity;
and target mechanisms of behavior change to promote and sustain behavioral and lifestyle change. These
foci simultaneously will advance science in these areas and reflects areas of substantial expertise within
our Roybal Center.
Faculty serving on the Administrative and Behavioral Intervention Development (BID) Cores will constitute the
Center’s Executive Committee. These faculty have extensive expertise related to the thematic foci of the
center and are committed to assisting to fulfill the mission of the Center. These faculty have experience
conducting research across all stages of the Stage Model and will work to transition promising interventions
across the Stage Model as quickly as possible. The MPI’s will serve as the Administrative Core co-leads and
provide oversight to and work collaboratively with the BID Core co-leads. The BID Core will provide grant
funding for up to two trials per year, one solicited from all departments across UIC and other University of
Illinois campuses and one solicited externally via a National competition. The overall performance of the
Center will be guided by a distinguished External Advisory Committee that includes representatives from
diverse academic, provider, funder, consumer, and media stakeholder groups; including health care systems
and plans. Collectively our work is expected to substantially advance science in these critically important
areas of focus and provide currently unavailable information about the impact of behavioral change
interventions that focus on underserved older adults.

Public health relevance
Overall Narrative Our proposed UIC Midwest Roybal Center for Health Promotion and Translation seeks to turn the findings of behavioral research interventions into real-world ways of improving the physical and brain health and quality of life of older adults at risk of Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD). Our renewal Center will continue to design interventions for older racial/ethnic minority adults while expanding our focus to reach those at risk of AD/ADRD using interventions that address brain health. This renewal application has four focus areas: 1) develop and test interventions to increase physical activity among older adults at risk of ADRD; 2) design interventions to maintain or improve brain health and mobility; 3) use technology to improve intervention delivery and quality; and 4) target mechanisms of behavior change to foster lasting lifestyle change.